Cell-type specific control of alcohol-associated behavior in the striatum

Project Summary
Alcohol Use Disorder (AUD) is a learning disorder in which alcohol alters neural circuits, causing a maladaptive
desire to seek and take alcohol. AUD can develop following repeated exposure, initiating a cycle of excessive
alcohol consumption, periods of abstinence, and relapse. Despite the prevalence and cost of this disorder,
treatment strategies are ineffective, especially in preventing relapse. It is well-known that cues associated with
the availability of alcohol can trigger seeking, increase drinking behavior, and contribute to relapse. Thus,
understanding the neural mechanisms encoding information about alcohol and associated cues is critical for
understanding how these associations develop and change with long-term drinking to contribute to seeking
behavior. The major goal of this proposal is to elucidate the neural mechanisms underlying cue-alcohol
associations and how they are changed by chronic alcohol exposure and abstinence.
Previous in vivo work from our lab has shown that D2-receptor-containing medium spiny neurons (MSNs) in
the nucleus accumbens (NAc) are critical for encoding associations between cues and outcomes and causally
control cue-associations at the population level. Importantly, our preliminary data indicates that D2 MSN
activity is dynamically modulated over time with alcohol drinking, specifically, in response to alcohol-associated
cues. However, the precise information encoded within the temporal activity of these D2 MSNs in vivo has not
been clearly defined – especially at the single-cell level. Additionally, D2 MSNs in the NAc receive direct
projections from multiple brain areas that are key to alcohol related behavioral dysfunction and these
glutamatergic inputs have been shown to be altered with alcohol exposure. However, whether these alterations
occur globally or at specific synapses has yet to be investigated.
This proposal will utilize microendoscopes to visualize single cell activity dynamics of D2 MSNs in the NAc
during operant alcohol self-administration to 1) define how D2 MSNs are engaged over the course of operant
alcohol drinking and 2) assess changes in D2 MSN activity associated with abstinence from chronic
intermittent ethanol (CIE) exposure and alcohol seeking. Next, using electrophysiology to measure functional
circuit adaptations, we will 3) assess the effects of chronic alcohol use and forced abstinence on physiology
and circuit connectivity of D2 MSNs in the NAc. I hypothesize that D2 MSN activity evoked by alcohol-
associated cues is increased over alcohol exposure and abstinence and that chronic alcohol exposure and
abstinence enhances circuit-specific glutamatergic drive onto D2 MSNs, affecting their physiological properties.
This proposal encompasses technical and theoretical training that will provide the foundational expertise and
conceptual thinking needed to address larger questions regarding how long-term exposure to alcohol changes
the brain and drives continued alcohol use. Additionally, these findings can ultimately inform our understanding
of underlying reward and learning processes and lead to more efficacious treatment interventions for AUD.

Public health relevance
Project Narrative Cues associated with the availability of alcohol can trigger seeking, increase drinking behavior, and contribute to relapse in alcohol use disorder, suggesting a critical need to understand the neural mechanisms encoding this information and how they change with long-term drinking and abstinence. This proposal aims to understand how neural circuits encode information about alcohol-associated cues in vivo and how chronic alcohol exposure impacts these circuits to drive alcohol seeking.